Statistical tensor regression models for intracranial aneurysm growth prediction

Project Summary/Abstract
Cerebral aneurysms occur in about 6% of the population and have a very high morbidity and mortality rate if they
rupture. Fortunately, most unruptured intracranial aneurysms (UIAs) rarely cause symptoms and do not require
an invasive treatment that may itself causes severe cerebrovascular disorders. However, it is very difﬁcult to
predict which UIAs will rupture. Recent evaluations of the hemodynamic features of UIAs, using 4D Flow MRI
(4DF), have shown promising results that suggest speciﬁc hemodynamic variables may have a great impact on
aneurysm growth or rupture. However, the clinical applicability of these hemodynamic variables in predicting UIA
growth has not yet been realized due to the lack of robust methods for gathering them, and also for describing their
relationship to UIA growth. To ﬁll in the gaps, the proposed research aims to develop a comprehensive statistical
and computational framework to predict: (a) the growth of UIAs at the 24th month (b) their growth trajectory over
a ﬁve-year period. Our goal is to develop a statistical framework to improve the UIA growth prediction that, in
turn, will improve the UIA rupture risk assessment. Toward achieving this goal, we will develop a unique tensor
regression machine learning framework that will (1) enhance 4DF resolution (2) predict the UIA growth at the 24th
month and (3) predict the longitudinal UIA growth trajectory. Successful completion of the proposed research will
provide a comprehensive computational system that can assist physicians when deciding whether a patient with
UIA needs treatment, or follow-up imaging, as well as the time interval for the surveillance imaging.

Public health relevance
Project narrative The proposed research aims to develop a comprehensive statistical and computational framework to predict the growth of unruptured intracranial aneurysms (UIA) growth at the 24th month as well as their growth trajecto- ries over a period of ﬁve years. Successful completion of the proposed research will provide a comprehensive computational system that will serve as a decision support tool for physicians managing patients with UIA. This information will also help physicians to assess the rupture risk of intracranial aneurysms, and to develop an appropriate plan for longitudinal surveillance based on the unique hemodynamics of a particular patient's UIA.